Prefrontal Cortex, Cognition, and Speech Symptoms in PD (PRECIS-PD)

Abstract
Parkinson’s disease (PD) impairs not only movement, but also cognition and speech. As PD progresses,
cognitive and speech symptoms become increasingly prevalent, heavily compromising quality of life and
often leading to loss of independence and placement in nursing homes. Few interventions improve these
dehumanizing aspects of PD, and current therapies for motor symptoms, such as levodopa and deep
brain stimulation (DBS), do not improve, and can even worsen cognition and speech. To mitigate these
deficits, a better understanding of the basic mechanisms leading to abnormal cognition and speech in PD
is needed. The prefrontal cortex (PFC) is critical for goal-directed planning of temporally sensitive
behavioral sequences essential for cognition and speech. In PD patients, the PFC is thinned, and our
published work demonstrates that PFC 4 Hz rhythms are decreased. Furthermore, PD involves diverse
pathophysiological processes such as disrupted dopamine, acetylcholine, and synuclein. There is a
critical need to understand how PD disrupts the PFC and leads to cognitive and speech symptoms. This
knowledge will inspire new biomarkers and targeted treatments for non-motor symptoms of PD.
The goal of the proposed Exploratory Grant is to catalyze novel collaborations that will lead to an Udall
Center of Excellence. We will test the overall hypothesis that decreased dopamine-dependent PFC 4 Hz
activity impairs cognition and speech in PD. We will identify cellular and circuit mechanisms underlying
PFC function and dysfunction in preclinical rodent models and in human PD patients. We will harness
complementary and convergent cutting-edge techniques, such as cell-type-specific 2-photon imaging of
the PFC in behaving animals, human intraoperative neurophysiology, brain imaging, and brain
connectivity. Common research themes focus on the PFC in cognitive and speech symptoms of PD,
neuronal oscillations, and neuronal circuits. Specific synergies among projects include our molecularly-
defined circuits, shared analytic tools, and the temporal organization of cognitive and speech functions
disrupted in PD.
We propose an Exploratory Grant. Project 1 will focus on cellular and circuit mechanisms of PFC 4 Hz
rhythms in rodents. Project 2 will focus on PFC circuits and systems in human intraoperative
neurophysiology. Project 3 will focus on Multi-modal analysis of human PFC in cognition and speech in
PD. The proposed research plan leverages our world-class clinical infrastructure at The University of
Iowa Parkinson’s Foundation Center of Excellence and catalyzes new synergies around cognition and
speech, which are greatly understudied facets of PD. Our work will lead to new targeted therapies for
those suffering from PD.

Public health relevance
Project Narrative Parkinson’s disease involves cognitive and speech dysfunction which leads to immense morbidity and mortality. There are no treatments that improve cognition and speech in Parkinson’s disease. This P20 planning grant builds a new collaborative team focused on understanding the basic mechanisms of cognitive and speech symptoms of Parkinson’s disease in prefrontal cortex. Our work will be critical for new biomarkers and treatments for patients with Parkinson’s disease.